Contact Pathway Activation on Vascular Devices

Project Summary
This project evaluates the contribution of contact activation to the progression of vascular device-related
blood coagulation and thrombus formation. Our work and findings to date have opened the window towards
the development of safer antithrombotic strategies. Our research will generate new knowledge supporting
the development of novel anticoagulants that lack dose-limiting toxicity, and cause less bleeding than current
drugs, while also helping to identify medical conditions that could benefit from the therapeutic use of these
contact activation inhibitors.
Vascular devices such as stents, grafts, hemodialyzers and oxygenators can activate blood and often
require the use of systemic antithrombotics to reduce the incidence or severity of device failure and
thrombotic events. Currently marketed antithrombotic drugs can help reduce clot formation on vascular
devices, but all increase the risk of bleeding. For instance, 30% of severely ill neonates that are treated with
extracorporeal membrane oxygenation (ECMO) experience severe bleeding complications, including
gastrointestinal, pulmonary and brain hemorrhage, which contribute to the high mortality rate of neonatal
ECMO. These and other vascular device-associated thrombotic and treatment-associated bleeding
complications signify the unmet medical need to improve the outcome of vascular interventions, including
permanent intravascular devices like stents and various forms of temporal extracorporeal organ support.
This program will now take a new direction to study the molecular mechanisms by which vascular devices
activate FXII to initiate thrombus formation at the blood-biomaterial interface, and evaluate the utility of
inhibiting the contact activation pathway in combination with anticoagulants or reduced platelet function. We
focus on FXII and FXI because (1) there appears to be a causal relationship between contact activation and
vascular device failure, and (2) targeting the contact activation pathway as a therapeutic approach is less
likely to have bleeding side effects for patients. Each Aim will have 3 subaims that will translate our (A)
mechanistic in vitro studies to (B) ex vivo blood flow studies of artificial surface-related thrombus formation
and (C) in vivo studies of vascular device-related thrombus propagation in 2 distinct animal models.
The potential significance of this translational project is that the knowledge generated will lead to verification
of promising, safe, and druggable molecular targets within the contact activation pathway to both prevent
and interrupt vascular device-related thrombosis. Our research may ultimately support the rationale for the
development of selective contact activation inhibitors that could benefit a large number of patients exposed
to vascular interventions and devices.

Public health relevance
Project Narrative Our work has pioneered efforts to evaluate the contribution of contact activation to the progression of vascular device-related blood clotting. Despite the use of currently available “blood thinning” drugs, which all have dose-limiting bleeding side effects, aberrant activation of the contact pathway of blood coagulation causes device failures, and contributes to significant vascular device-associated morbidity and mortality. The research will generate new knowledge supporting the development of novel anticoagulants that are significantly safer, lack dose-limiting toxicity, and cause less bleeding than current drugs while helping to identify medical conditions that could benefit from the therapeutic use of these contact activation inhibitors.